Administrative Core

PROJECT SUMMARY: ADMINISTRATIVE CORE
The Administrative Core is responsible for governance, management, oversight, and quality control of the
research, training, education and dissemination missions of the Center. Administrative Core functions include
facilitation of the scientific vision and research goals of the Center; allocation and management of resources,
with a focus on data management across projects; establishment of timelines and deliverables; development of
policies and procedures; purchase of equipment and supplies; preparation of reports; dissemination of work
products and data sharing; and community outreach and education. The Administrative Core also fulfills a
critically important but less metric-driven leadership function for the Center: to continuously foster a culture of
transdisciplinary collaboration and inquiry that supports the unique contributions of all Center members and
fosters a respectful and joyful culture of diversity and inclusion.
The Administrative Core is governed by the Center’s Steering Committee, which addresses ongoing Center
activities, reviews research project needs and progress, removes barriers to the accomplishment of Center
goals, and resolves conflicts. The Steering Committee is supported by the following: 1) A Data Management
and Data Quality Assurance Program that ensures a high level of data integrity; 2) A Training, Education, and
Career Development Program; 3) A Dissemination and Outreach Program that translates scientific findings into
knowledge for learners, practitioners and community partners; 4) An Internal Advisory Board (IAB) to provide
oversight, advice, and critical review of Center policies and activities; 5) An External Scientific Advisory Board
(ESAB) that ensures the highest scientific timeliness and excellence of the Center’s research projects.